Elucidating the Molecular Mechanisms that Mediate DKD Progression in Patients Living with HIV

SUMMARY
With the aging of the HIV-infected population, and their prolonged exposure to cART regimens that may promote
the development of diabetes, the prevalence of diabetic kidney disease (DKD) is increasing in patients living with
HIV (PLWH). In two recent studies, we and others have confirmed the additive/synergistic effects of HIV infection
and diabetes on the progression of DKD. Studies have demonstrated that HIV can infect kidney cells, and that
the kidney serves as a reservoir for HIV replication. Recent findings suggest that HIV is present in the kidney
even in cART-treated HIV patients. To determine how chronic HIV infection in patients with low or undetectable
viral load aggravates DKD, we generated a doxycycline-inducible kidney cell-specific HIV transgenic mouse the
expresses low levels of HIV genes. With this model, we confirmed that low level of HIV gene expression did not
cause kidney injury alone. However, aggravated DKD was observed after induction of diabetes, suggesting an
additive/synergistic effect of HIV and diabetes on DKD progression (Feng J. Kidney Int. 2021). For this project,
we will further investigate the molecular mechanisms by which chronic HIV infection induces the progression of
DKD in both mouse models and human patients with HIV to accelerate the discovery of new drug targets and
therapeutics to treat these patients. Toward this goal, we propose the following specific aims: Aim 1: Perform
comprehensive bulk and single-cell RNA-sequencing of the kidneys and kidney immune cells from the mice with
both diabetes and low HIV gene expression as compared to control mice, and mice with HIV or diabetes alone.
Aim 2: Perform formalin fixed paraffin embedded slides-based RNA-capture sequencing, scRNA-seq,
immunostaining, and in-situ hybridization of kidneys from patients with DKD alone, and from those with both HIV
infection and DKD. Aim 3: Integrate these datasets together with publicly available datasets to identify gene
expression signatures mediating the additive/synergistic effects of HIV and diabetes on DKD progression. Utilize
the Connectivity Mapping approach to identify potential drugs and small molecules which could reverse these
gene signatures similarly to the approach described in our recent study (Zhang L. Diabetes 2020). Develop a
web-portal to serve and interact with all project data. Aim 4: Validate predicted drugs from aim 3 in the animal
model described in the aim 1. Overall, this project will enable us to identify potential new mechanisms, new drug
targets, and potential new therapeutics to halt the progression of DKD in PLWH.

Public health relevance
PROJECT NARRATIVE HIV-infected patients in the United States now live longer, owing to the effective antiretroviral therapy, but the prevalence of chronic kidney disease continues to increase in this HIV-infected population due to comorbidities with diabetes, hypertension, and HCV. This study will unravel the molecular mechanisms of how chronic HIV infection contributes to the progression of age-related kidney disease, specifically diabetic kidney disease. The knowledge gained will enable the development of effective targeted and personalized therapies.